Identify and study the roles of key genes and proteins in subpopulations of Alzheimer's disease patients with uncoupled neurofibrillary tangles

Project Abstract
Alzheimer’s disease (AD) affects about 10% of the US population of age 65 and up, and roughly 40
million people worldwide. Despite decades of studies, the disease etiology of AD still remains unclear,
and till today, there is no curative treatment for AD. Typically, AD patient brains show characteristic
neurofibrillary tangles (NFTs), which are composed of aggregated bundles of microtubule-associated
protein tau in its truncated or hyperphosphorylated state, and the degree of NFTs in the brain usually
positively correlates with the disease progression and cognitive decline. However, there also exists
subpopulations of patients whose disease trajectories do not follow the typical NFT accumulation way. A
subgroup of patients’ brain samples showed AD-like high NFTs but with no or low cognitive deterioration,
while another subgroup of patients presents severe cognitive impairment but low NFT pathology.
Studying these atypical AD subtypes and identifying key factors in such uncoupling between NFT
pathology and cognitive impairment will not only improve precision medicine in AD, but also provide
valuable information on how to prevent and slow down cognitive deterioration during the long disease
progression.
In this project, our overarching hypothesis is that the transcriptomic, proteomic, and network-level
differences identified for the atypical NFTs-dementia uncoupled human brains can contribute to the
mechanisms of rapid cognitive deterioration in low-NFT AD groups and the dementia resilience in
Asymptomatic AD groups. We plan to apply data-driven approaches with integrative genomic analyses
on multiple AD proteomic and transcriptomic datasets to identify candidate genes, proteins, and
coexpression networks that play important roles in the NFTs-dementia uncoupling in the atypical AD
patients. The identified gene candidates will be further screened in the Drosophila strains expressing
human pathological tau for causal genes and proteins that are key factors for either NTF-dementia
uncoupling or rendering neuron protection/susceptibility to AD. Promising candidates obtained from
Drosophila experiments will be further tested in the mouse strains which can express human tau as early
as four months old to understand their roles in terms of neuron-protection or AD-susceptibility. Our long-
term goal is to generate experimental evidence for further grant applications to elucidate the NFT-AD
uncoupling mechanisms behind the two subgroups, which can open new research directions for AD
prevention as well as AD drug development.

Public health relevance
Project Narrative The burden of Alzheimer’s Disease is large, yet no effective therapeutics exist for any of these devastating disorders. In this proposal, we will apply data-driven approaches on two atypical AD subtypes of samples, then compare with samples for typical AD to identify gene/protein pathways or networks that are specific to these two groups. We will further investigate the roles of the identified genes and pathways using transgenic fruit flies and mouse tauopathy models for mechanistic study, through which we hope to find treatment options for AD.